An organ-on-a-chip model system to study prostate cancer metastasis into vascularized bone

PROJECT SUMMARY
Based on “seed and soil” theory, certain tumors exhibit a predilection for metastasis to particular organs. For
example, bone is the most common site of metastasis for prostate cancer, happening in ~90% of patients with
advanced stages of prostate cancer. Organ-on-a-chip models of cancer metastasis have emerged as a powerful
predictor of cancer progression. However, despite the development in organ-on-a-chip platforms for in-vitro
studies in metastasis, research in bone metastasis on-a-chip remains largely underdeveloped, and the only few
available models in the literature lack the complex mineralization and the inclusion of bone cells, especially
osteoclasts into the system, which are essential elements in order to study bone remodeling. Here, (aim 1) we
will use a novel organ-on-a-chip platform with a highly mineralized and calcified cell-laden hydrogel including
osteoclasts to determine the influence of mineralization and the cross-talk of prostate cancer cells and bone cells
on the process of preferential prostate cancer growth in bone and the consequent bone resorption. A potentially
rate-limiting step in metastasis formation is the extravasation process that involves adhesion of tumor cells to
endothelial cells and their transmigration through the endothelial cell monolayer and basement membrane. It has
been well-established that pericyte-support of EC capillaries is required for formation of non-leaky vessels and
perturbation of the EC-hMSC linkage, therefore results in leaky vessels. The role of pericytes in tumor metastasis
has been mostly focused on tumor angiogenesis and the research on the role of this cell type on cancer
extravasation has remained underdeveloped. Here, (aim 2) we will use the bone metastasis-on-a-chip platform
to test the role of pericytes in a vasculature embedded in a mineralized bone matrix in inhibiting human prostate
cancer extravasation as well as the effects of factors released by cancer cells on vasculature integrity. We argue
that this multi-pronged strategy will enable the engineering of in-vitro bone metastasis-on-a-chip model system
to understand the preferential metastasis of prostate cancer to the bone and bone destruction as well as the role
of pericytes in prostate cancer extravasation through the vasculature. Ultimately, this project will lead to model
systems that can be used for studying cancer metastasis to bone and developing new treatments.

Public health relevance
PROJECT NARRATIVE This project seeks to develop an organ-on-a-chip platform that mimics the cellular and extracellular characteristics of human bone with specific application in bone cancer metastasis process. Several aspects that are of central importance to the success of developing this organ-on-a-chip for prostate cancer metastasis to the bone will be addressed, including the growth of prostate cancer cells in a bone-like tissue and bone destruction as well as the mutual effects of pericyte-supported vasculature and prostate cancer extravasation. We contend that the results of this project will provide an experimental in-vitro platform for better understanding the prostate cancer metastasis to bone, enabling to develop more effective treatments.